AOU-CE SUPPLEMENT

The Lamar Soutter Library (LSL) of the University of Massachusetts Medical School (UMMS) proposes to serve as the National Network of Libraries of Medicine, New England Region (NN/LM NER) for 2016-2021. The central location of the UMMS, fifteen years of experience serving as the NER, strong institutional support from the highest levels of UMMS administration, and long-standing relationships with hospital, academic and community partners, all make the LSL uniquely qualified and positioned to carry out the functions of the NN/LM NER. The Overall Component describes the framework for the structure, organization, and functions of NER and the overall evaluation plan. Each of our specific aims serve to promote the products and services of the National Library of Medicine (NLM), expand the reach of the NLM, and foster collaborations with Network Members and other organizations to improve access to and sharing of health and biomedical information resources to a diverse and broad audience throughout the six New England states.

Public health relevance
Public Health Relevance Statement Improving the public's health is an enormous task that involves a massive, complex mixture of professionals and organizations that work together to achieve the mission of ensuring a healthier population. The mission can only be achieved when evidence- based information is made available at the fingertips of healthcare professionals, the public health workforce, librarians, patients, researchers, educators, community based organizations and others contributing to improve the health of the community. The National Network of Libraries of Medicine, New England Region (NN/LM NER) through its network of libraries, health-related institutions, community based organizations and other partners provides the infrastructure, products and services for the provision of equal access to authoritative biomedical information to those who need it, in the format they need it, and at the time they need it.